Regulated cGAS activation in HSV-1-associated neuropathogenesis.

Title: Regulated cGAS activation in HSV-1-associated neuropathogenesis
Dementia is characterized by a progressive loss in memory and cognition. Alzheimer's disease
(AD) is the most common dementia that has aging as the most significant risk factor. Genetics
plays a major role in AD development and prognosis, which is further influenced by environmental
factors, such as microbial infection. Herpes simplex viruses (HSV) are ubiquitous pathogens in
the human population and reaches nearly 100% in citizens of 65 or older. HSV-1 is a neurotropic
large DNA virus and implicated in AD development, representing a major environmental factor for
AD and AD-related dementia.
Inflammation is a common feature observed in brains of both AD model mice and human AD
patients. One pathway triggering inflammation in the brain is the cytosolic DNA-mediated
activation of cGAS and downstream inflammatory response. Though emerging studies implicate
cytosolic DNA and cGAS in the development of AD and ADRD via provoking inflammation, a
number of pressing questions remain unanswered. Central to these unanswered questions is the
nature of cytosolic DNA and the regulation of DNA-cGAS-mediated innate immune activation.
This proposal will address this question with a de novo synthesized DNA-protein crosslinker to
profile the cytosolic cGAS-binding DNA in HSV-1-infected brain and probe the dynamic regulation
of cGAS activation by a metabolic enzyme. This metabolic enzyme plays pivotal roles in regulating
cGAS activation and downstream inflammatory response. Our work is expected to reveal
molecular detail of cGAS activation and regulation by a metabolic enzyme in the
neurodegeneration induced by a ubiquitous human pathogen.

Public health relevance
Project Narrative Inflammation and metabolic stress are two main features of neurodegeneration of Alzheimer's disease (AD) and AD-related dementia. cGAS mediates innate immune inflammation is implicated in diverse infection and inflammation- associated disease and cGAS regulation in neurodegeneration is not well understood. This proposal will apply an innovative toolkit and small molecule inhibitors to investigate molecular details that cytosolic DNA engages cGAS in inflammation during neurodegeneration during HSV-1 infection and normal aging, thus providing a proof-of-concept to target cGAS activation in taming inflammation and neurodegeneration.